The mechanism of gp78 ubiquitin ligase in suppressing hepatocellular carcinoma

SUMMARY
The goal of this project is to elucidate the mechanism by which the gp78 E3 ubiquitin (Ub) ligase suppresses
the progression of hepatocellular carcinoma (HCC). Liver cancer is among the most common causes of cancer
death worldwide. According to the statistics from American Cancer Society, an estimated 42,810 new cases of
liver cancer will be diagnosed, and 30,160 people will die of this disease in the United States in 2020. HCC is
the predominant form of primary liver cancer and is extremely difficult to treat because most patients are diagnosed
in a late stage and few can benefit from surgery (liver resection and liver transplantation). Sorafenib remains the only
drug available for HCC and increases survival time by mere 3 months. Thus, it is imperative to develop new and
efficient approaches for the treatment and diagnosis of HCC. However, this task has been hampered by poor
understanding of the molecular mechanism behind the progression of HCC. Our recent study demonstrated that the
gp78 E3 Ub ligase is a tumor suppressor of HCC. As an E3 Ub ligase, the main function of gp78 is to target
protein substrates for degradation by the Ub-proteasome system. Loss of gp78 likely leads to accumulation of
substrate proteins, thereby contributing to the pathogenesis of HCC. To gain insight into the role of gp78 in
suppressing HCC, we have initiated a proteomic analysis for liver proteins that are degraded in a gp78-
dependent manner. Here we report the identification of MYBL2 as a novel gp78 substrate. MYBL2 is a
transcription factor that activates multiple genes whose protein products promote cell cycle progression and cell
proliferation. Overexpression of MYBL2 has been observed in liver cancer and is associated with poor survival
of HCC patients. Thus, MYBL2 is a potential liver oncoprotein. We hypothesize that gp78-mediated
degradation of MYBL2 may play an important role in suppressing HCC. To test this hypothesis, we will
investigate the mechanism underlying gp78-mediated ubiquitylation of MYBL2 (Aim 1) and demonstrate the
effects of blocking MYBL2 degradation on liver cell tumorigenesis (Aim 2). The proposed research will not
only shed light on the role of gp78 in suppressing HCC, but potentially identify a target for the treatment and
diagnosis of this dreadful disease.

Public health relevance
The proposed research will elucidate the mechanism of the gp78 ubiquitin ligase as a tumor suppressor that suppresses the progression of hepatocellular carcinoma. This project will lead to a paradigm shift in the therapeutic approaches for prevention and treatment of liver cancer.